Intracellular Innate Immune Receptors in Cancer Suppression and Immunotherapy

Abstract
The challenges addressed by this R35 application are multiple. First, colorectal cancer (CRC) remains a
leading cancer worldwide that is resistant to many treatments. Two important risk factors for CRC are a history
of chronic colitis or inflammatory bowel disease (IBD) and obesity, both of which are increasing at an alarming
rate. However, the mechanisms linking these predisposing factors to CRC are not well understood and thus
there is a pressing need to elucidate these basic mechanisms. Second, obesity is also a contributing factor to
other gastrointestinal cancers, where the role of innate immunity receptors is less well-defined than CRC.
Understanding the roles of innate immunity in these other cancers is a high priority. Third, the interaction of
host genetics, microbiome, inflammation and cellular transformation is complex, but fundamental to the onset
of gastrointestinal cancers. Elucidating this network of interaction is important for devising new approaches for
cancer therapy. Fourth, while the roles of adaptive immune molecules and cells have been the main stake of
cancer immunotherapy, much less emphasis has been placed on innate immune receptors which may alter
adaptive immunity to advance cancer immunotherapy, which should be an attractive strategy to combat
cancer. Finally, while studies in animals are important in establishing a foundation, a well-defined plan to
translate basic findings to humans remains the ultimate goal and challenge that we will address.
The NLR (nucleotide-binding domain, leucine-rich repeat containing proteins, or nucleotide-oligomerization
domain receptor) is a multi-member gene family that encodes a group of cytosolic proteins that are involved in
the intracellular sensing of microbial products as well as damage-associated molecular patterns. NOD2, an
NLR family member, has a strong genetic association with Crohns' disease and has been implicated in colitis-
associated CRC. Additionally, NLRs including NOD2 and NLRP12 can affect the microbiome to impact colitis
in mice, suggesting that NLR family members are important in maintaining or disrupting the homeostasis of gut
microbiome. We and others have shown a role for the inflammasome NLRs in models of colitis and CRC. In
addition to our analyses of well-studied inflammasome components in models of colitis and CRC, we have
been at the forefront of defining a strong role for other NLRs which have anti-inflammatory functions (referred
to as inhibitory NLRs), and can alter the course of inflammation and cancer. This proposal plans to examine
the roles of NLRs in humans and in murine models of cancers, to elucidate the complex interaction of NLRs
with the microbiome and cellular transformation and to harness these proteins to enhance cancer
immunotherapy.

Public health relevance
Project Narrative This proposal will focus on a family of of intracellular innate immune receptors that we first described and their profound impact on cancers. We will explore their roles in myriad modes of cancer suppression or exacerbation including those associated with inflammation and obesity. In addition, we will explore the trio network of innate immunity, microbiome and cancer, and explore ways to utilize these interactions to improve anti-cancer immunotherapy.